Core B: Tissue Procurement and Processing

Project Description: Tissue Procurement and Processing Core B
The Tissue Processing and Procurement Core will establish a central resource to procure, process, catalog, and
distribute all human tissues for the research projects in this center. This will build upon the ongoing collaborations
established by investigators in the Washington University Pain Center. We will obtain human tissues from our
local organ procurement organization Mid-America Transplant (DRG, spinal cord, nerve), the National Disease
Research Interchange (DRG), and neurosurgical procedures (DRG, nerve) and orthopedic surgery (nerves) at
Washington University School of Medicine. Dr. Bryan Copits will oversee all aspects of this core, which will use
this established network of tissue sources, our validated tissue processing procedures, our knowledge of best
practices for tissue preservation for all downstream applications in the research projects, and databases for
handling de-identified patient medical histories. Tissues will be cataloged and linked to de-identified patient
medical history using OpenSpecimen software, and transferred to the Siteman Cancer Center Tissue
Procurement Core at Washington University in St Louis to take advantage of their extensive expertise in
coordinating tissue storage and distribution. All investigators will have access to these tissue and medical records
through OpenSpecimen to easily request samples from this Core. This Core will also coordinate with other U19
Centers in the PRECISION Human Pain Network to establish uniform protocols for human tissue procurement
and processing.